Influence of 5-HT1b Activation on the Abuse Related Effects of Cocaine

ABSTRACT
Cocaine use disorder continues to be a significant public health concern. Despite strides in our understanding
of the neurobiological underpinnings of cocaine addiction in preclinical models, a limited amount of research
has translated those findings into clinical populations. Such translation is crucial to identify neurobiological
circuits that contribute to the problems posed by cocaine use disorder and to guide treatment based on those
clinical neuroscience findings. Cocaine potently inhibits the reuptake of serotonin (5-HT). Increased synaptic 5-
HT resulting from this reuptake inhibition activates multiple 5-HT receptor subtypes. Some of these receptor
subtypes have been implicated in the abuse-related effects of cocaine, including its primary reinforcing effects
(i.e., cocaine taking behavior). 5-HT1b receptors play a particularly important role in cocaine effects, likely
because they are highly expressed in the mesocorticolimbic system. Preclinical data show that zolmitriptan, a
commercially available selective 5-HT1b agonist migraine medication approved for human use, selectively
attenuates the reinforcing and other abuse-related effects of cocaine. The overarching goal of this project is to
advance these promising preclinical findings into clinical populations, thereby demonstrating that the 5-HT1b
system plays a key role in the effects of cocaine in humans. To this end, 20 non-treatment seeking human
subjects meeting diagnostic criteria for cocaine use disorder will sample doses of intravenous cocaine (0, 10
and 30 mg/70 kg) in experimental sessions after 3 days of maintenance on oral zolmitriptan (0, 2.5, 5 and 10
mg). A placebo-controlled, double-blind, within-subjects design will be used such that all subjects experience
all dose conditions in random order. The study will require an approximately 1-month admission to our inpatient
unit. After sampling a cocaine dose, subjects will make nine choices between that dose and an alternative
reinforcer (US$6.00) on a concurrent progressive-ratio choice task that was developed and validated in our
laboratory. A battery of subjective drug-effect measures and tasks that assess distinct domains of impulsivity
will be completed during the same experimental sessions in which cocaine choice is assessed. The research
proposed here will directly translate findings from preclinical research and provide the initial clinical evidence
that 5-HT1b activation, achieved through administration of zolmitriptan, reduces the reinforcing and other
abuse-related effects of cocaine, as well as cocaine-associated impulsivity. This study will also provide basic
science information about the serotonergic mechanisms underlying the pharmacodynamic effects of cocaine in
humans. As such, the outcomes will advance our understanding of the clinical neurobiology of cocaine
addiction.

Public health relevance
PROJECT NARRATIVE The serotonin 5-HT1b system plays key role in the effects of cocaine, as indicated by numerous preclinical studies. No clinical neuroscience research has advanced these preclinical findings, limiting our ability to determine whether the 5-HT1b system also contributes to cocaine use in humans. The proposed research will fill that gap by determining how administration of a 5-HT1b agonist, zolmitriptan, impacts the abuse-related effects of cocaine in humans.